Engineered multi-therapeutic agents delivery system towards retinal ganglion cell axon regeneration

PROJECT SUMMARY
In the U.S., approximately 2.2 million people suffer from optic neuropathies, accounting for 9 to 12% of
all cases of blindness. Of them, 10% of patients that receive proper medical treatment continue to experience
vision loss, which obviously needs an alternative treatment strategy.
One of current treatments utilizes neurotrophic factors (NTFs) to increase retinal ganglion cell (RGC)
survival, responsible for the visual function. While direct administration of NTFs via intravitreal injection has
had some success, a susceptibility to denaturation of these NTFs limits its clinical success. Also, the delivery
of NTFs alone may result in limited treatment success since optic neuropathies accompany neurodegeneration,
caused by the neurotoxic cycles.
To resolve these problems, we have engineered polymeric nanoparticles that mimic negatively charged
sulfonate groups in natural heparin and deliver multiple therapeutic agents to continuously supply NTFs and
inhibit the neurotoxicity. The advantages of our strategy include: 1) sustained delivery of NTFs at target site,
mimicking continuous NTF transport, 2) prolonged bioactivity of NTFs encapsulated in the system and 3)
sustained delivery of an anti-neurotoxic agent, continuously inhibiting neurodegeneration during the
progression of optic neuropathies.
We have constructed this application under two specific aims: (1) determine an appropriate
nanoparticle formulation for the co-delivery of the multiple therapeutic agents and (2) evaluate RGC axon
regeneration in rat optic nerve crush model.

Public health relevance
NARRATIVE The number of medical treatment options for optic neuropathies has continuously increased with new drugs being developed every few years; however, despite this contribution, the percentage of patients experiencing vision loss is significant. An alternative treatment strategy has been developed, in which an engineered nanoparticles system addresses neural injuries in a one-time treatment platform that removes patient compliance as a barrier to therapeutic success. The material will be developed as a co-delivery vehicle of multiple therapeutic agents to enhance its functionality, which is expected to support retinal ganglion cell survival in patients with optic neuropathies as well as provide a platform to develop nerve regenerating materials for other central nervous systems.